Identifying the origins of resilience through human single cell molecular networks, then testing them in diverse, resilient, human IPS lines

PROJECT SUMMARY
Much of late-life cognitive decline cannot be explained by Alzheimer’s disease (AD) or other common age-
related neuropathologies. In fact, every individual is either resilient or susceptible to AD to a certain extent,
due to their unique genetics and environment. Over the past 15 years our center has identified numerous
environmental and psychological risk factors associated with faster or slower cognitive decline, and several
molecular markers of resilience, that point to the existence of molecular networks that underlie resilience. The
proposed project builds on this prior work. The overall goal of this proposal is to define the complex
molecular basis of resilience to AD, using brains with various levels of resilience and in vitro human
model systems, to identify novel therapeutic targets for cognitive decline. To do this, we will take a
genome-wide approach to identify key molecular drivers of resilience in specific cell types in the human brain.
Then we will perform rigorous tests of the molecules we have identified using brain cells from many different
humans. Specifically we will see if we can genetically stimulate these cells to become more resilient to the
effects of aging and Alzheimer’s disease. Two key innovations separate this project from previous work. The
first aspect is our focus on individual cell types. Typically molecular measurements of brain data contain a
mixture of dozens of cell types. We will measure each of these cell types individually, using single-cell
RNAseq (scRNAseq), to identify which cell types are most related to resilience to AD. Within these specific
cell types we will use computational network analysis to identify a smaller number of gene genes within the
molecular systems affecting resilience. These predictions facilitate the 2nd aspect of this study which is
unusual, which is our plan to change these genes in a human model of AD. The model we will use are
neurons and glial cells derived from 50 individuals with different level of resilience to the common sporadic
form of Alzheimer’s. We will use genome engineering to affect the abundance of genes that we predict are
related to resilience in all of these cell lines. In this way we can check for resulting gene expression signatures
of resilience as well as cellular phenotypes associated with health cognition, which persist in the face of AD
pathology. The proposed project will deliver a comprehensive set of molecular networks and key molecules
that underlie resilience to AD and other common brain pathologies. It will do so by breaking common barriers
to progress in this area: 1) accurate identification of targets through a single cell approach and computational
network methods, and 2) testing in realistic human models. The proposed project will provide high-confidence
targets for therapeutic development. Thus, the proposal will have a strong and sustained impact on the field.

Public health relevance
PROJECT NARRATIVE Some older individuals have excellent cognitive function despite their brains showing high levels of pathology associated with Alzheimer’s disease. From such individuals, we will learn about the molecular basis of their resilience to Alzheimer’s, and test these predictions in neurons grown from these same brains. These tests will show if we can essentially copy these natural forms of resilience and also provide high-value drug targets.